Skeletal Muscle Health Protects Vascular Function in Obesity

PROJECT SUMMARY
Obesity remains the most persistent threat to cardiovascular health in the United States. Exercise
mitigates much of this risk, but the therapeutic benefits of exercise are frequently beyond the capabilities of the
aged, the very obese or those with prior injuries. Understanding the mechanisms of the beneficial properties of
exercise on the cardiovascular system could identify targets that replicate or enhance the salutary effects of
physical exertion. Despite this well-recognized paradigm, targets remain elusive. Prior work from our laboratory
has determined that preserving skeletal muscle mass and performance through deletion of myostatin, a negative
regulator of muscle growth, improves redox balance and nitric oxide signaling in the vasculature and
cardiovascular health in obese mice. This improvement occurs despite no change in physical activity, indicating
that the metabolic state of skeletal muscle is an important mechanism underlying the preservation of
cardiovascular health. The goal of this application is to determine the mechanisms linking specific improvements
in skeletal muscle metabolism with vascular health in obesity.
In preliminary data for the current proposal, we have identified three potential mechanisms. The first is
that an expanding fat mass in obesity results in increases in CYP1B1 expression in skeletal muscle. CYP1B1 is
an extrahepatic monooxygenase that hydroxylates estrogen (and other metabolites) that can cause muscle lipid
accumulation. We will test the hypothesis that CYP1B1 is a mediator of skeletal muscle dysfunction and
vascular injury in obesity. Secondly, activation of lipogenic pathways results in myosteatosis, the ectopic and
inappropriate accumulation of lipids in muscle. Because exercise and deletion of myostatin reduce steatosis in
skeletal muscle in parallel with improved vascular health, we will test the hypothesis that resolving
myosteatosis by preventing the synthesis of lipids, protects vascular health in obesity. Finally, we have
discovered that deletion of myostatin results in the massive upregulation of sarcolipin, a novel micropeptide that
uncouples SERCA function to increase mitochondrial fat oxidation. We will test the hypothesis that selective
upregulation of sarcolipin in the skeletal muscle of obese mice is a therapeutic strategy to reduce excess
lipids and restore cardiometabolic health. We will accomplish these goals using novel, state of the art tools
to manipulate gene expression in lean and obese mice and unravel the integrated pathways that undermine
cardiovascular function in obesity.

Public health relevance
PROJECT NARRATIVE Obesity increases cardiovascular disease risk by mechanisms that remain poorly understood. New data from our labs suggest that maintaining muscle quality in obesity protects the function of the vascular endothelium in ways that mimic exercise. This application will investigate new mechanisms in muscle focused on the inappropriate accumulation of lipid in muscle cells as potential therapeutic opportunities for limiting vascular disease in the obese population.